PCIR CORE

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. Primary support for the subproject and the subproject's principal investigator may have been provided by other sources, including other NIH sources. The Total Cost listed for the subproject likely represents the estimated amount of Center infrastructure utilized by the subproject, not direct funding provided by the NCRR grant to the subproject or subproject staff. PARTICIPANT AND CLINICAL INTERACTION RESOURCES FUNCTION (PCIR) APPLICATION OVERVIEW The Accelerating eXcellence In translational Science (AXIS) will be the catalyst to implement the CDU Research Strategic Plan and will become the integrated home for clinical and translational research. The structure of the CDU AXIS includes an innovative and proactive governance structure, the AXIS Concierge Desk, and nine key functions/activities. The Concierge Desk (clinical and translational research infrastructure) will be a physical and virtual (Web site) hub that will bring all research services together by providing consultation, training and education, and community engagement resources offered throughout the functions. The Collaborations and Partnerships Function will provide resources, locations, research, and other activities that will draw community and academia together to explore cross communication and partnerships. The Multidisciplinary Training and Career Development Function will streamline and centralize all faculty development activities across the University. The Community Engagement and Research Function is a formal mechanism to organize community resources and integrate community into the educational process at CDU in order to bring community expertise to interdisciplinary research teams. The Research Design and Biostatistics Function will provide consultation and training activities in research design and biostatistics. The Participant and Clinical Interactions Resources Function will integrate a system to make resources and expertise in design and biostatistics more readily available across the University to support investigators engaged in translational research and will represent an upgrade in functionality of the Clinical Research Center. The Regulatory Knowledge, Ethics, and Support Function will provide direct support, assistance, and consultation to research facilitators and researchers;share best practices;and develop innovative programs. The Biomedical Informatics Function proposes to consolidate and expand the support services, making them available to all investigators and faculty across all disciplines to boost the effectiveness of implementation of knowledge into medical policy and practice. The Technology and Resources for Core Laboratories Function proposes to realign the support services and resources for investigators across all CDU disciplines and among collaborating institutions in an effort to enhance the quality of science. The Pilot Project Program describes the plan to solicit proposals, prioritize projects, and review methodologies and research performance. PCIR will integrate and coordinate its resources to train, equip, and support the translational research teams of today and tomorrow. PCIR will ensure that technological discoveries, specialized facilities, and research materials needed for patient-oriented research are accessible to investigators involved in health disparities research at CDU. Additionally, it will enable researchers to provide new prevention and treatment strategies and allow specialized knowledge, customized programs and services, unique information resources, and improved education and training to become accessible to all researchers at CDU.